Analysis Core

PROJECT SUMMARY/ABSTRACT – ANALYSIS CORE
Our UCSF Center for Aging in Diverse Communities (CADC) Analysis Core (AnC), funded since 1997,
develops, advances, and applies qualitative and quantitative methods toward understanding and improving
disparities in aging populations. To reduce health disparities requires identifying mechanisms by which
multilevel determinants (e.g., environmental, social, family, individual) affect disparities. Measures are needed
that are culturally appropriate and psychometrically sound in the disparity populations. To ameliorate health
disparities, we need to design and deliver high-fidelity interventions that reflect scientific evidence and are
relevant to older adult disparity populations. Translating evidence-based interventions developed for the
general population to meet the needs of disparity populations requires innovative, community-engaged
methods. In the 2012-2017 cycle, we published papers describing a framework for translating evidence-based
interventions into community settings to reach diverse older adults, and methods for modifying existing
measures for diverse populations. We mentored CADC Scientists (minority early investigators focused on
disparities in older adults) on developing and publishing new measures of engagement in advance care
planning, childhood socioeconomic factors, impacts of vaginal atropy, and immigration stress. In the next
cycle, we will continue to advance and disseminate innovative research methods appropriate for older adult
disparity populations, provide training and consultation to our CADC Scientists and other investigators in these
methods, and disseminate them broadly to the scientific community. Our specific aims are to: 1) advance and
disseminate methods of conducting community-engaged behavioral interventions in older adult disparity
populations that (i) account for and appropriately meld multiple sources of evidence, (ii) utilize community
resources and assets (iii) assure 'fit' to the community context and the disparity population, (iv) promote active
participation by community members, and (v) ensure high-fidelity intervention delivery; 2) increase availability
of multilevel measures of risk and protective factors, mediators, and health outcomes for use in older adult
disparity populations and facilitate selection of optimal measures in research on older adult disparities
populations; and 3) promote and advance the use of broadly applicable, advanced qualitative and quantitative
design and analysis methods in health disparities research, including those appropriate for community-based
RCTs, quasi-experiments, and observational research designs, as well as analyses of primary or secondary
data. By developing, refining, and disseminating these methods for appropriate measurement as well as
conducting and evaluating community-engaged behavioral interventions, we will continue to contribute to
national efforts to reduce health disparities in older adults. By providing training/mentoring on these methods
to our CADC Scientists and other aging-related researchers focused on older adult disparity populations, we
will increase our national capacity to conduct needed research.